Human cellular model of midline crossing to study developmental neurological disorders

ABSTRACT
Defects in establishing midline connectivity in the developing human nervous system are
associated with multiple neurological disorders. However, there are no self-organizing
human cellular models to study midline-guided axonal crossing. My laboratory has been
developing methods for guided differentiation of regionalized neural organoids and we
have shown that these can combined to study cell-cell interactions and circuit formation
in preparations called neural assembloids. Here, we propose to generate a novel human
stem cell-derived multi-cellular model of the developmental processes underlying the
spinal cord midline crossing of axons. To achieve this, we will generate and functionally
characterize organoids that resemble the human floor plate, and then assemble them
bilaterally with organoids resembling the dorsal spinal cord to derive midline assembloids
and recapitulate midline crossing of human axons. We will then systemically apply this
microphysiological system to study axon guidance defects following loss of
neurodevelopmental disease genes.

Public health relevance
NARRATIVE Progress in understanding neurological disorders has been hindered by a lack of access to live neural cells from patients for direct investigation by imaging, recording, and manipulation. We propose to build a novel stem cell-derived human assembloid model of midline crossing to study how human axons develop in human CNS development. We plan to systematically apply this platform to understand the cellular phenotypes and molecular mechanisms of genetic neurological developmental disorders.